Clinical Research Pilot Project Program

6. PROJECT SUMMARY – PILOT CORE
The Pilot Core will provide funding to studies of innovative ideas or hypotheses that, if successful, will lead to
improvements in the understanding, prevention, diagnosis, or treatment of hyperphenylalaninemia, biopterin
defects, and related disorders. The core will fund the development of novel laboratory assays or instruments,
assessment of novel biomarkers, execution of pilot clinical trials, or performance of pilot data mining studies on
data accumulated from the longitudinal natural history study.